The Role of Reactive Astrocytes in the Propagation and Clearance of Tau in Alzheimer's Disease

PROJECT SUMMARY/ABSTRACT
While for decades reactive astrocytes surrounding amyloid-β (Aβ) plaques and phospho-tau (pTau)
neurofibrillary tangles in Alzheimer’s disease brains have been identified by their high levels of the cytoskeletal
intermediate filament glial fibrillary acidic protein (GFAP), the downstream effects of this GFAP upregulation on
the progression of these AD neuropathological changes remain obscure. Importantly, our preliminary data from
an Alzheimer’s disease tau transgenic mouse model indicate that GFAP overexpression in astrocytes actually
attenuates pTau hippocampal pathology, suggesting that GFAP upregulation by reactive astrocytes in
Alzheimer’s disease may be a neuroprotective response of astrocytes against pTau-induced neurotoxicity rather
than a ubiquitous, non-specific epiphenomenon accompanying the neurodegenerative process. Our central
hypothesis in the present proposal, supported by these preliminary data, is that GFAP upregulation by astrocytes
ameliorates trans-synaptic neuron-to-neuron pTau propagation through increasing pTau uptake and clearance.
Further rationale for this hypothesis includes the following facts: (1) Alzheimer’s disease progression is driven
by the trans-synaptic neuron-to-neuron propagation of proteopathic pTau species along neural networks; (2)
astrocyte peri-synaptic processes are integral part of tripartite excitatory synapses and GFAP is critical for
intracellular vesicular transport to and from these peri-synaptic processes; (3) astrocytes have been implicated
in the clearance of pTau and other misfolded protein aggregates; and (4) GFAP has been involved in chaperone-
mediated autophagy through its interaction with LAMP2A at the lysosomal membrane—suggesting a link
between GFAP levels and astrocyte proteostasis. Our overall goal is to elucidate the contribution of reactive
astrocytes to Alzheimer’s disease progression and evaluate their potential for neuroprotective therapeutic
applications. We will investigate whether astrocyte GFAP has a protective effect on neuron-to-neuron
propagation of pTau across synapses in an in vivo mouse model of Alzheimer’s disease-like pTau seeding and
propagation (Aim #1); determine whether increasing GFAP levels enhances pTau uptake and clearance by
astrocyte cell models (Aim #2); and interrogate the GFAP interactome with quantitative proteomics to learn about
putative molecular mediators of GFAP effects on proteostasis (Aim #3). Since the extent of pTau neurofibrillary
tangle pathology strongly correlates with the severity of cognitive decline associated with Alzheimer’s disease,
filling this fundamental knowledge gap could further our understanding of the role of reactive astrocytes in
Alzheimer’s disease clinical progression. Upon successful completion of these aims, our expected outcome is to
have delineated the roles of GFAP upregulation by reactive astrocytes in both pTau propagation along neural
networks and pTau uptake and clearance by astrocytes.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health as it focuses on both elucidating the role of reactive astrocytes in tau spreading across synapses in Alzheimer’s disease—the main driver of its clinical progression—and testing a novel alternative strategy to inhibit this process. Since astrocytes are essentially neuroprotective in the normal brain, understanding the consequences of reactive astrogliosis in the Alzheimer’s disease brain has the potential for significant advances in the development of astrocyte-directed neuroprotective therapeutic strategies. Thus, the proposed research is relevant to the NIH/NIA mission of slowing down Alzheimer’s disease-related rate of cognitive decline.